Polarized Exocytosis: Rhos, Rabs, Tethers and SNAREs

ABSTRACT The overall goal of this proposal is to understand the mechanism by which Rho GTPases, Rab GTPases, tethering agents, and SNAREs contribute to direct polarized trafficking and growth at the cell surface. Previous work from our laboratories and others has implicated members of the Rho/Cdc42 and Sro7/Tomosyn/Lgl protein families as factors that have important roles in both polarity and membrane trafficking to the cell surface in yeast and neurons. Spatial regulation of trafficking in yeast requires specific patterns of Rho/Cdc42 localization as well as tight regulation of vesicle tethering and fusion by the exocyst complex and Lgl/Sro7 protein. In this proposal, we will examine the mechanism by which Sro7 acts as a Rab-dependent tethering agent in exocytosis, and how gain-of-function mutants in the exocyst which mimic Rho GTPase activation of the exocyst complex, structurally change in order to upregulate its activity as a Rab-dependent tethering agent. Additionally, we will explore the hypothesis that a novel schizophrenia-linked protein with homology to an endocytic SNARE protein, acts to regulate exo/endocytic trafficking in the neuron.

Public health relevance
Project Narrative: Our investigation into the fundamental mechanisms by which cells direct growth is likely to be relevant to our understanding of a diverse set of human diseases including tumor development and Type II diabetes as defects in this process has been associated with a number of cancers and insulin responsiveness in humans. Our work on understanding the function of a gene product recently associated with schizophrenia in humans will help to create a cell biological system in which to connect this gene's function to the development of neuropsychiatric disease. Understanding how these processes work at a molecular level will allow development of new approaches and novel therapeutics to combat disease.